Targeting Inflammasome Mediated Neuronal-Microglial Crosstalk as a Therapeutic Substrate in c9orf72 FTD/ALS

ABSTRACT
Of the various genetic causes of familial Amyotrophic Lateral Sclerosis (ALS), repeat expansions of the G4C2
promoter of C9orf72 account for ~40% of the cases, while the same mutations accounts for 18% of familial
Frontotemporal Dementia (FTD) cases. Clinical overlap exists between the two disorders as the frequency of
FTD symptoms can be detected in up to 50% of ALS patients. The prevalence of ALS and FTD symptomatic
overlap is far greater in patients with repeat expansions in the G4C2 of C9orf72 than in patients with sporadic
forms of ALS, the rate of disease progression in C9orf72 positive patients is also more rapid. Such overlap in
clinical symptoms suggest C9orf72 mutations recruit related pathophysiological pathways responsible for
overlapping neuropathological manifestations in ALS and FTD. Of the various risk factors for the development
of FTD/ALS, military service significantly increases the odds ratio for the diagnosis of FTD/ALS in military
veterans compared to non-military personnel. Veterans are uniquely vulnerable to the development of
FTD/ALS due to its correlation with traumatic brain injury (TBI), compared to other types of dementias13. The
overarching goal of this proposal, entitled “Targeting inflammasome mediated neuronal-microglial
crosstalk as a therapeutic substrate in c9orf72 FTD/ALS”, is to evaluate the therapeutic efficacy of
targeting CXCL10 induced neuroinflammation in vivo in a model of c9orf72 frontotemporal dementia-
amyotrophic lateral sclerosis with Eldelumab, a CXCL10 neutralizing antibody. We utilize a well-
established and characterized model containing 100 repeats of the dipeptide repeat protein (DPR) Glycine-
Arginine (GR). Our feasibility studies suggest that neurons expressing GFP-(GR)100 release stress signals,
including CXCL10. CXCL10 induces NLRP3 inflammasome activation, thereby promoting the release of
proinflammatory IL-1β and IL-18. Genetic ablation of the NLRP3 inflammasome attenuated mortality, motor
function, anxiety, and contextual memory, in vivo. The proposed studies will evaluate targeting CXCL10
mediated neuroinflammation as a therapeutic intervention. Furthermore, we will evaluate the presence of this
crosstalk mechanism in vivo in models of other causes of genetic FTD/ALS. To test the utility of targeting this
mechanism presymptomatically/symptomatically, through the utilization of mouse models with Designer
Receptors Exclusively Activated by Designer Drugs (DREADD) coupled to the CXCR3 receptor on microglia in
the models of FTD/ALS we will investigate the effects of targeting CXCL10 (regardless of cellular source).
Finally, we will evaluate the efficacy of Eldelumab, an anti-CXCL10 monoclonal antibody, which has been
previously clinically trialed for Crohn's disease, ulcerative colitis, and rheumatoid arthritis, with a known human
safety profile. Collectively, these innovative studies will evaluate the efficacy of targeting CXCL10 as a
treatment for FTD/ALS, further characterize the role of neuroinflammation in the pathogenesis of the
disease, and evaluate the ability of Eldelumab to be employed as a therapeutic. We appreciate the
significance of sex consideration in the interpretation and generalizability of scientific results, therefore, to
achieve rigorous and translatable results, we will perform analyses on balanced samples of male and female
mice, providing data disaggregated by sex, as well as grouped by sex. Our secondary analyses in the GFP-
(GR)100 model of ALS/FTD have suggested both male and female mice are susceptible to impairment in our
assessed behavioral paradigm.

Public health relevance
Narrative This proposal entitled “Targeting inflammasome mediated neuronal-microglial crosstalk as a therapeutic substrate in c9orf72 FTD/ALS” leverages our previous studies where we identified a disease mechanism in FTD/ALS by which neurons in the brain can release signals to induce neuroinflammation, thereby exacerbating neurodegeneration. We found that by targeting an innate immune complex involved in this process that motor function, cognitive function, and ultimately survival can improve. Our propose studies will further investigate this mechanism and evaluate its ability to be targeted therapeutically by employing a monoclonal antibody. Furthermore, as this neuronal-microglia crosstalk mechanism may be present presymptomatically, we propose utilizing an in vivo animal model whereby we can temporally control the expression of the signaling molecule.